Novel Regulators of Beta Cell Proliferation and Function

Diabetes is one of the leading causes of morbidity and mortality in the veteran population. The Veteran
population are particularly susceptible for diabetes, with a staggering 70% of Veterans at risk for diabetes. 25%
of all Veterans have diabetes, similar to that seen in older Americans from the general population. A failure to
increase the β-cell proliferation and functional β-cell mass in response to increasing metabolic demand from
insulin resistance associated with obesity and aging, underlies most causes of adult onset diabetes in
veterans. It is, therefore, imperative to identify pathways that regulate functional β-cell mass that could be
leveraged for treating β-cell failure and diabetes. Our data demonstrate that Tead1, a critical transcriptional
effector of the mammalian Hippo pathway, is robustly expressed in mouse and human islets and has a non-
redundant role in regulating β-cell proliferation and function. The mammalian Hippo-Tead1 pathway consists of
a core kinase cascade, culminating with Lats1&2, inhibitory kinases, that phosphorylate coactivators, Yap and
Taz, preventing their nuclear translocation and co-activation of Tead1-mediated transcription regulating cell
proliferation and apoptosis. The premise for this proposal rests on our preliminary data that strongly suggest
that Tead1 is the switch regulating the proliferation restriction, while promoting mature function in adult β-cells.
Recent reports have found some contrasting results, wherein, (a) Yap-Tead1 act as an enhancer in many β-
cell maturation genes in human embryonic pancreatic progenitors, (b) Yap has also been shown to inhibit
endocrinogenesis in mice, and acquisition of mature function during differentiation of human iPS cells
(hIPSCs), but (d) sufficient to induce proliferation in human islets, ex vivo. Preliminary data shows that β-cell
specific Tead1 deletion leads to diabetes and glucose intolerance. Tead1-null islets display a decrease in
expression of mature β-cell markers and a loss of glucose stimulated insulin secretion. Furthermore, our data
indicates that embryonic Tead1 deletion in β-cells also led to profound diabetes suggesting that Tead1 is
required in the endocrine progenitors for normal differentiation. To comprehensively test the regulation of β-cell
differentiation, proliferation and function by the Hippo-tead1 pathway, we hypothesize that Tead1 regulates
β-cell proliferation and acquisition of mature function via context-dependent co-factor specific,
transcriptional regulation of a network of proliferation and mature-phenotype defining genes. The
broad goal is to mechanistically delineate key pathways regulating functional β-cell mass that can be
harnessed to promote human β-cell proliferation with preserved function, through genetic loss- and gain-of-
function studies using in vivo mouse models and ex vivo mouse and human islets and human iPSCs. We will
specifically 1. To test if enhancing Yap activity in adult β-cells in vivo is sufficient for β-cell proliferation
and maintenance of mature function via co-activation of Tead1, in GOF studies (overexpressing
constitutively nuclear phospho-mutant YapS112A specifically in adult mouse β-cells using a Tet-On system) in
inducing proliferation and expansion of β-cells under high fat diet induced insulin resistant stat, identifying
direct targets of Tead1 in β-cells under basal and proliferating states and delineate Tead1 dependent and
independent Yap targets in β-cells. 2. Test if mammalian Hippo-Tead1 pathway is required for human β-
cell differentiation and proliferation by assessing if Yap/Taz-Tead1 regulates iPSC differentiation into
pancreatic progenitors and β-cells and identify the molecular targets of Tead1 in this process. We will also test
if modulation of Tead1 activity improves β-cell function and proliferation in isolated human islets and if this
regulatory role is impaired in diabetes. Collectively the proposed studies will critically address how the Hippo-
Tead1 pathway regulates β-cell function and proliferation in human β-cells. With the significant rise in incidence
of diabetes in veterans, there is an urgent need to develop novel therapies to reverse declining functional β-cell
mass and successful completion of the proposed experiments will address this critical need.

Public health relevance
More than 1.5 million veterans have diabetes and this is associated with a significant increase in complications and death. All diabetes is associated with an inability to compensate by increasing the number and function of the insulin producing β-cells in the pancreas to meet the metabolic needs. The precise molecular mechanisms regulating β-cell compensation are poorly understood. With compelling preliminary data that Tead1 regulates β-cell proliferation and function in mice, we propose to identify molecular mechanisms underlying the regulation of β-cell proliferation, differentiation and acquisition of mature function by Tead1 in human β-cells, using human iPS cell-derived β-cells, to translate the findings from mouse studies to diabetes therapy in humans. Successful completion of the proposed experiments will help close the knowledge gap in our understanding of the regulation of proliferation and differentiation in human β-cells and will help develop novel therapies that preserve and restore β-cells to cure diabetes.